Evaluating a remotely delivered, digital health CRC screening intervention among racially diverse patients of a community health center

Project Summary/Abstract
Colorectal cancer (CRC) screening is one of the most effective tools to reduce cancer morbidity and mortality.
Yet, CRC screening rates at federally qualified health centers (FQHCs) in rural areas lag behind more well-
resourced healthcare systems and national goals. Improving CRC screening in rural FQHCs requires attention
to the needs of their patient populations as well as their limited resources for implementation; yet, little
research has tested CRC screening programs with FQHCs that are culturally responsive, contextually relevant
and alleviate implementation burden. Our long-term goal is to scale implementation of CRC screening
solutions that will reduce inequities that burden FQHCs. Our team has developed a novel digital health
platform, mPATH-Cloud, that has the potential to help alleviate implementation burden on clinical teams by
automating many key processes, all the while delivering CRC screening communication, education, and
services in ways that have proven to be culturally responsive, patient-centered, and effective. Thus, our study
seeks to evaluate mPATH-Cloud with rural FQHCs to demonstrate effectiveness at improving guideline
concordant screening and identify critical implementation processes and outcomes that will impact future
dissemination and scalability. We will use an embedded experimental mixed methods model, which includes
an individual randomized trial of the multi-component intervention, quantitative and qualitative measures to
identify ways to improve tailored messaging and adapt strategies to improve effectiveness across diverse
patient profiles, and quantitative and qualitative measures of processes and outcomes to improve
implementation. Our team is well-situated to lead this research, which if successful, will lead to progress
toward reducing inequities in low-income rural communities served by FQHCs.

Public health relevance
Project Narrative mPATH-Cloud is an innovative digital health platform that delivers evidence-based and culturally responsive communication and navigation to help patients receive colorectal cancer screening, a widely recommended test that decreases mortality. However, while this type of technology has proven effective for routine, face-to- face primary care appointments, there is increasing interest and demand for reaching more diverse and marginalized patients beyond the confines of the traditional clinical visit. This project will determine the effectiveness and optimal way to implement mPATH-Cloud as fully remote and culturally responsive strategy for increasing CRC screening among low-income, rural and racially diverse patients.